Understanding the Drivers of Antibiotic use in the Treatment of Childhood Diarrhea and Relationship to Antibiotic Resistance in China

ABSTRACT
By the age of 5, children in low and middle-income countries (LMICs) are exposed to nearly five times more
antibiotics than high-income country children. Although improved access to antibiotics has been a major driver
of mortality declines, most antibiotics administered to children are clinically unnecessary. Excessive use can
lead to adverse events, drug toxicity, and harm the gut microbiota and immune system. It also contributes to
antimicrobial resistance (AMR), the costs of which are disproportionately borne by children in LMICs. Although
widespread clinically unnecessary use of antibiotics in LMICs is well-documented, substantial knowledge gaps
remain regarding the drivers of overuse among children and how these are linked to the dynamics of
resistance and disease. This knowledge is required to design policies and interventions that appropriately
balance access and overuse. This K01 Award proposal focuses on identifying incentives that caregivers and
providers face to treat children with antibiotics and how these are related to the development of resistance. My
career goal is to become independent scholar working at the intersection of economics and infectious disease
epidemiology with a focus on research to inform AMR policies in LMICs. The proposed training activities build
on my background as an economist and experience conducting population-based experimental research with
further training in infectious disease epidemiology, the biomedical underpinnings of antimicrobial resistance,
machine learning techniques, and agent-based modeling of infectious disease and social systems. Aligned
with my training goals, my research program aims to integrate concepts from economics and infectious
disease epidemiology and to use state-of-the-art machine learning approaches to examine the complex
relationship between factors driving demand for antibiotics, disease, and the development of resistance. To do
so, I will draw on existing micro-level data from a survey of clinicians and households across 360 rural villages
in southwest China as well as new experimental data on the prescription practices of clinicians and
pharmacists in the same area. My specific research aims are 1) to experimentally evaluate the prescribing
practices of clinicians and pharmacists for pediatric diarrhea cases; 2) to estimate the influence of clinician
advice on antibiotic use in children, and how this varies with patient, clinician, and community characteristics;
and 3) to develop an agent-based model of health-seeking behavior, antibiotic use, and bacterial resistance for
pediatric diarrhea cases in rural China and use this model to conduct counterfactual simulations to prioritize
interventions for future study. My mentoring team has specialized training in infectious disease epidemiology,
the epidemiology of antimicrobial resistance, machine learning, and agent-based modeling as well as
experience leading interdisciplinary teams. This research will generate new insights that can inform policies to
better balance access to antibiotics and overuse. The training and research proposed in this K01 award will
support the development of future R-level proposals to study the design of AMR policies in LMICs.

Public health relevance
PROJECT NARRATIVE This project focuses on antibiotic use for treatment of diarrheal disease among children and the relationship to the development of antibacterial resistance in rural China. With data from an audit study in clinics and pharmacies and a micro-level survey of households in southwest China, I will explore the drivers of antibiotic use, both on the supply side with clinicians and pharmacists and the demand side among parents and caregivers, using machine learning-based quasi-experimental statistical analysis and agent-based modeling to identify various drivers of antibiotic demand, to simulate the effects of alternative policies on antibiotic use and antibiotic resistance, and to identify promising policies and interventions for future study. The outcomes of this research will contribute to knowledge of the behavioral drivers of population-level antibiotic use and resistance and support the development of policies and interventions suited to low and middle-income countries.